Molecular Pathways Regulating Tissue-resident Memory T cells in the Gut

Abstract
The intestinal mucosa has a rich immune microenvironment capable of responding rapidly to invading pathogens
while maintaining a regulated homeostatic state to commensal microbiota and dietary proteins. Tissue-resident
memory T cells are critical for immune homeostasis at mucosal surfaces based on their ability to rapidly respond
to invading pathogens. The CTLA-4 and PD-1 receptors inhibit T cell function and have become major
therapeutic targets for boosting T cell-mediated immunity in cancer patients. However, targeting of these
inhibitory receptors frequently induces inflammatory adverse events, and colitis is one of the most common and
severe inflammatory adverse events induced by checkpoint inhibition (CPI). We recently reported an in-depth
single cell analysis of immune cells in the mucosa of CPI colitis patients and healthy subjects. This analysis
demonstrated dramatic accumulation of CD8 T cell populations with highly proliferative and cytotoxic states in
all studied CPI colitis patients. We used the T cell receptor (TCR) sequences of CD8 T cells to investigate the
origin of these clonally expanded T cells. Interestingly, we discovered that a large fraction of colitis-associated
cytotoxic CD8 T cells had the same TCR sequences as tissue-resident memory CD8 T cells. We therefore
hypothesize that the CTLA-4 and PD-1 inhibitory receptors hold tissue-resident memory T cells (Trm) in
check, and that loss of these inhibitory signals can induce massive clonal expansion of Trm, a major
step in the development of CPI colitis. Antibody blockade of CTLA-4 and PD-1 receptors in individuals with
immunologically normal mucosa thus provides insight into the physiological function of these receptors in
humans. In Aim 1, we will investigate how the CTLA-4 and PD-1 receptors regulate the function of Trm cells,
both in humans and murine models. We will investigate whether targeting of inflammatory pathways may revert
T cells from highly proliferative, cytotoxic states back into a Trm state by performing an in-depth single cell
analyses on colon biopsies from CPI colitis patients enrolled in a separately funded randomized phase 2 clinical
trial that evaluates TNFα blockade versus corticosteroids. Our single cell analysis demonstrated upregulated
TNF gene expression signatures in CPI colitis, and retrospective clinical data indicate that TNFα blockade is
efficacious in CPI colitis. We will also investigate this hypothesis in murine models by evaluating the impact of
CTLA-4 and PD-1 antibodies on the activation and cytotoxic states of CD8 T cells in the gut mucosa. In Aim 2
we will study the spatial interactions of T cell populations with immune, epithelial and stromal cells in the intestinal
mucosa using the CODEX technology that enables highly multiplexed immunofluorescence analysis of tissue
sections using panels of DNA-barcoded mAbs. This high-dimensional imaging approach affords an opportunity
to study the cell – cell interactions in the healthy gut mucosa and in CPI colitis, including biopsy specimens from
the clinical trial described in Aim 1. This project thus addresses a fundamental question is mucosal immunology.
1

Public health relevance
Narrative This project focuses on investigating the molecular mechanisms that control the function of tissue-resident memory T cells in the gut. We will study these important immune cells both in the healthy colon and in colon inflammation induced by PD-1 and CLTA-4 antibody therapy, both in humans and relevant mouse models.